2023 Cellular and Molecular Mechanisms of Toxicity Gordon Research Conference and Seminar

ABSTRACT
Collaboration across the many areas of toxicology research including the environmental sciences and
pharmaceutical and consumer product development, is critical for scientific advancement as scientists across
many professional sectors including academia, private industry and government strive to solve crucial public
health problems. The Cellular and Molecular Mechanisms of Toxicity (CMMT) Gordon Research Conference
(GRC) boasts a rich history of presenting the latest unpublished innovations in mechanistic toxicology research
within a collegial environment. A key focus of the CMMT GRC throughout the years has been to foster a strong
sense of community by encouraging scientific exchange, networking, and career development throughout the
conference week, which has been known to carry forward into attendees' careers. After a 2 year postponement
due to the COVID pandemic, the 2023 week-long program has been refreshed under the theme “Modernized
Approaches to Mechanistic Toxicology Investigations” and aims to highlight scientific advancements across the
various professional sectors of toxicology. Working with a Steering Committee, the Chairs assembled a diverse
group of Discussion Leaders and Speakers representing broad interests and scientific backgrounds from across
the globe. The scientific sessions, keenly focused on mechanistic toxicology, cover broad topics including
functional genomics, artificial intelligence, environmental toxicant metabolism, modernized developmental
toxicity testing, impact of the cellular microenvironment on toxic responses, and integration of new approach
methodologies in risk assessment for multiple focus areas including mixtures, neurotoxicity, and new therapeutic
modalities. Attendees are encouraged to submit abstracts for daily poster sessions from which late-breaking oral
presentations will be selected. The program will also feature a Power Hour, which serves as a venue to address
challenges faced by women in science and promote discussions on diversity. For the first time, it will focus on
challenges for women with intersectional identities and will be led by active toxicologists who are also known
advocates in the field and leaders in the Society of Toxicology Special Interest Group, Out Toxicologists and
Allies. To further increase diversity, the Chairs will proactively recruit attendees from several special interest
groups across toxicological societies. Fostering development of trainees continues to be a central focus of the
CMMT GRC and the 2023 conference will again include a 1.5 day Gordon Research Seminar (GRS). The GRS
program will include a keynote session on translational toxicology, a career development session on creating an
effective digital presence, and several opportunities for late-breaking oral and poster presentations. Trainee
development will continue by inclusion of 2 trainees selected from the GRS, alongside emerging stars from
across the U.S. and abroad, for an early career investigator session in the GRC program. Despite COVID-related
delays, the GRC and GRS Chairs, along with Discussion Leaders and Speakers are eager to provide an exciting,
cutting edge program in 2023 that continues the long-held tradition of scientific community forged in prior years.

Public health relevance
NARRATIVE Gordon Research Conferences (GRCs) are renown for bringing together scientists at all career stages to discuss the latest advancements in their scientific field and for fostering future collaborations. The 2023 Cellular and Molecular Mechanisms of Toxicity GRC aims to expand the tradition by emphasizing collaboration and learnings from scientists expanding the breadth of the toxicology field. The theme of the 2023 meeting is “Modernized Approaches to Mechanistic Toxicology Investigations” with scientific sessions designed to highlight key learnings and techniques applicable to multiple professional sectors including the environmental, chemical, consumer product, and pharmaceutical sciences while also providing a platform for trainee presentations in an early career investigator session and the accompanying Gordon Research Seminar.